Progestins' non-genomic actions for socio-sexual behavior

Progesterone (P) mediates exploration, anxiety, social and sexual (socio-sexual) behaviors of female rodents in part through actions of its product, 3[unreadable]-hydroxy-5[unreadable]-pregnan-20-one (3[unreadable],5[unreadable]-THP). In the ventral tegmental area (VTA), 3[unreadable],5[unreadable]-THP has actions to facilitate socio-sexual behavior through GABAA/Benzodiazepine (GBRs) and/or NMDA type glutamate (NMDARs), rather than via intracellular progestin receptors. 3[unreadable],5[unreadable]-THP levels in the midbrain VTA both facilitate, and are enhanced by, socio-sexual behavior. The pregnane X receptor (PXR) mediates the production of, and/or metabolism to, various neurobiological factors. PXR is localized to the midbrain VTA of rats. Our hypothesis is that PXR-dependent biosynthesis of 3[unreadable],5[unreadable]-THP in the VTA underlies facilitation of, and/or response to, socio-sexual behaviors. Using classic behavioral endocrinology, pharmacology, and radioimmunoassay methods, in conjunction with tools of molecular biology, in a rat model of socio-sexual behaviors, aims will be to investigate. 1) The causal actions of PXR in the midbrain VTA for 3[unreadable],5[unreadable]-THP to facilitate socio-sexual behaviors. 2) The effects of socio-sexual behaviors on PXR-dependent midbrain 3[unreadable],5[unreadable]-THP levels. If PXR and 3[unreadable],5[unreadable]-THP are altered in response to socio-sexual behaviors, and blocking PXR attenuates behavior-induced 3[unreadable],5[unreadable]-THP, then effects of 3[unreadable],5[unreadable]-THP in the midbrain to mediate, and be dynamically altered by, socio-sexual stimuli are PXR-dependent. 3) 3[unreadable],5[unreadable]- THP can be formed in the VTA from metabolism of P produced peripherally by ovaries or adrenals or centrally via biosynthesis in brain. The role of PXR for 3[unreadable],5[unreadable]-THP in the VTA to be produced from central biosynthesis and/or metabolism from peripheral P to facilitate, or be increased by, socio-sexual behaviors will be investigated. 4) 3[unreadable],5[unreadable]-THP may have PXR- dependent actions involving GBRs and/or NMDARs. Whether behavioral effects of 3[unreadable],5[unreadable]- THP, or 3[unreadable],5[unreadable]-THP formation in response to socio-sexual behaviors, are in part due to PXR-dependent effects at GBRs and/or NMDARs, will be examined. Investigating novel behavioral functions of 3[unreadable],5[unreadable]-THP will extend our knowledge of the neurobiology of progestogens, relevant for socio-sexual behaviors, and their connections to systems that regulate emotions. 3[unreadable],5[unreadable]-THP is implicated in stress regulation, pathophysiology and/or treatment of neuropsychiatric disorders. Thus, further understanding of 3[unreadable],5[unreadable]-THP's role and mechanisms to enhance reproduction/social bonds, minimize aggression, influence affective aspects of social behaviors, and to mediate responses to stress, are essential.

Public health relevance
Project Narrative Progestogens mediate exploration, anxiety, social and sexual (socio-sexual) behavior in rodents, in part through non-classic actions in the midbrain ventral tegmental area (VTA), and can be enhanced by engaging in socio-sexual behaviors. The role of the pregnane xenobiotic receptor (PXR) in mediating formation of progestogens and their non-traditional actions in the midbrain VTA will be investigated. Elucidation of PXR as a mediating factor in this phenomena will provide greater understanding of the mechanisms of progestogens underlying sex and/or hormonally-mediated effects on social and/or affective processes, and/or the etiology and/or treatment of some stress-sensitive neuropsychiatric disorders. Further understanding of progestogens' effects and mechanisms are vital to provide insight into normative and pathophysiological processes.